Contribution of pulmonary ionocytes and neuroendocrine cells to ion transport-mediated airway surface liquid maintenance

PROJECT SUMMARY/ABSTRACT
Regulation of ion transport across the epithelium is vital to the health and function of the airways. Active
and passive ion and water movement is responsible for maintaining a periciliary fluid layer through which cilia
can move mucus and protect the airways against particles, irritants, and pathogens. While there is clear
evidence of disease caused by specific ion channel mutations (CFTR) as well acquired ion channel dysfunction
during/contributing to disease severity (COPD, asthma), the contribution of individual cell types of the
pulmonary epithelium to ion transport maintenance is poorly understood. Our experimental evidence
demonstrates that alterations in the frequencies of pulmonary ionocytes and neuroendocrine cells in airway
epithelial cultures result in dramatic differences in ion transport properties. Altogether, these cell types, along
with tuft-like cells, comprise about 0.8% of the total cell numbers in the human tracheal epithelium. Pulmonary
ionocytes are a newly identified cell type in the airways with extremely high expression of many ion channels
with vital functions in the respiratory tract. The dramatic impact of ionocytes and pulmonary neuroendocrine
cells on the ion transport properties of human airway cultures despite their rare frequencies led to our
hypothesis that these cell types are highly involved in the regulation and maintenance of ion transport balance
across the entire epithelium and are able to impact ion transport functions in other cell types through
intercellular communication. By utilizing novel murine models and applying innovative techniques to primary
murine and human airway epithelial cells, the research outlined in this proposal will define the contribution of
these rare cell types to the overall ion transport functions of the airway epithelium and will also define the role
of CFTR in these cells. We will thereby fully characterize the significance of pulmonary ionocytes and
neuroendocrine cells to ion transport-mediated airway surface liquid regulation and identify potential cell and
ion channel targets for therapeutic treatment of common airway diseases.

Public health relevance
PROJECT NARRATIVE Maintaining proper ion transport is a vital function of the airway epithelium, as it is a necessity for proper moistening and protection of the airways through airway surface liquid and mucociliary clearance. Dysregulated ion transport and impaired mucociliary clearance underlie cystic fibrosis and, to some extent, COPD and asthma. We will define the contribution of different unique rare airway epithelial cell types to overall ion transport of the epithelium, examine alterations in their function during modeling of disease states, and clarify the potential of targeting ion transport in specific cells for the treatment of airway diseases.